Administrative Core (with Enrichment Program)

The overall mission of the UCSD/UCLA DRC centers on fostering research in the prevention and treatment of
diabetes and its complications to ultimately improve the lives of patients. For the past twenty two years, our
DRC has uniquely linked together the diabetes/metabolism activities of two major universities within the UC
system. Thus, we have been able harness the collective energy and scientific excitement at UCSD, UCLA and
affiliated institutions, which together comprise the major proportion of research in diabetes/metabolism in
Southern California. The DRC has fostered new collaborations and interactions between outstanding scientists
within and across these institutions, and has played an important role in promoting the careers of young
scientists as they move on to the status of independent investigators. Our research base faculty membership
includes outstanding scientists who have been exceptionally successful, as judged by the numerous
publications in high impact journals and the generous peer review grant support that they have accrued. The
administrative component is the organizing force behind the DRC, and provides leadership for all of the Cores
and Programs. The overall objective of the Administrative Core is to ensure smooth and efficient operation of
all DRC components, to allow optimal interaction with DRC faculty members and between the various Cores
and Committees to promote and enhance diabetes/metabolism research. The Administrative Core is
responsible for fund and budgetary management, communications, academic enrichment and planning and
organization for DRC activities. The Administrative Core also prepares progress reports and renewal
applications, coordinates all committee business and provides general administrative assistance to the various
elements of the program.